The Eleanor M. Saffran Conference on Cognitive Neuroscience of Rehabilitation of Communication Disorders

Project
Summary.
The overall goal of this conference is to create an environment that fosters conversation among scientists, clinical
practitioners, educators and students who share a common interest in rehabilitation of communication disorders.
In addition, this year marks the beginning of a concerted effort to honor the principle of “Nothing about us without
us” by intentionally including people with lived experience of the conditions that are the subject of discussion.
For this year, that means including d/Deaf and hard-of-hearing individuals. We anticipate that this annual
`meeting-of-minds' will facilitate translation of basic and patient-oriented research to development and
implementation of diagnostic and rehabilitation practices that are evidence-based and yet clinically feasible. We
also anticipate that students at all levels (undergrad to post-doctorate) who attend this conference will incorporate
the translational/ implementation model into their `thinking' as they progress through their education and move
forward in their clinical and/or research careers.

Public health relevance
This year's Saffran Conference aims to enhance evidence-based practice by integrating research and praxis, paying particular attention to the academic and professional experiences of experts in deaf and hard of hearing communities. Many of the speakers and attendees will use American Sign Language with interpreters. In this way, all attendees can experience a deeper understanding of the causes and consequences of language deprivation in the deaf and hard of hearing.